SOMOS Alianza: Developing a Strategic Alliance across Three HIV Epicenters to Achieve Ending the HIV Epidemic Goals among Latino MSM

Project Summary
Florida (FL) and Puerto Rico (PR) were two of seven jurisdictions accounting for 84% of the national increase in
HIV incidence among Latino MSM from 2010-2014. Fueling the problem, evidence-based HIV-prevention and
treatment interventions for Ending the HIV Epidemic (EHE) are insufficiently scaled up in both regions. For
example, in PR, only 5.7% of PrEP eligible Latino MSM were taking it. In addition to similar disparities across FL
and PR HIV epicenters (i.e., Miami Dade County/MDC, Orlando/Orange County, San Juan Municipio), there is
significant migration between these epicenters, suggesting the utility of forming a strategic alliance and sharing
interventions and implementation strategies across jurisdictions to achieve EHE goals. Accordingly, the aims of
this project are as follows: Aim 1: Form a strategic alliance between three EHE jurisdictions tied by
migration and within which LMSM experience HIV disparities. We will form a strategic alliance – SOMOS
Alianza – between MDC, Orange County, and San Juan. The significance of this partnership is underscored by
(1) all jurisdictions being EHE priorities, (2) similar HIV disparities among LMSM in all jurisdictions, and (3)
migration between jurisdictions. Aim 1 will involve establishing, engaging, and monitoring outcomes of the
alliance. Engagement activities will involve in-person and virtual meetings guided by network weaving (an
implementation strategy) to set goals, identify assets and strengths in each jurisdiction that could be translated
to other jurisdictions, and speed networking/matchmaking to promote connections, scaling out innovations, and
developing new implementation research and practice projects. We will monitor outcomes of alliance
membership. The alliance will include implementation (e.g., Florida DOH, Puerto Rico GCAP, and FQHCs),
community (individuals with lived experience), and scientific partners. Aim 2: Leverage the strategic alliance
to adapt our implementation strategy (JUNTOS Referral Network) for scaling up HIV-prevention and
treatment services to LMSM to two new jurisdictions. We will leverage the strategic alliance from Aim 1 to
adapt the JUNTOS Referral Network which we are developing for MDC, to be usable in San Juan and Orange
County as well. We will use ADAPT-ITT1,2 to carry out the adaptation. Using theater testing, we will show alliance
members from San Juan and Orange County the MDC prototype of JUNTOS. They will describe modifications
to make JUNTOS acceptable, appropriate, and feasible (Proctor's implementation outcomes) for use in San
Juan and Orange County. Their feedback will inform adapted prototypes of JUNTOS. Collectively, Aims 1 and 2
will add value by (1) creating a strategic alliance between EHE priority jurisdictions to achieve EHE goals and
(2) leveraging the alliance for one specific adaptation project. These activities will further EHE goals as well as
lay the foundation for a multi-site R01 implementation-science focused research study testing the utility of
JUNTOS for improving implementation and increasing LMSM demand for HIV-prevention and treatment
services, aligned with EHE priorities.

Public health relevance
Project Narrative Evidence-based interventions for Ending the HIV Epidemic are insufficiently scaled up to Latino MSM, resulting in HIV disparities. Three key EHE jurisdictions in which Latino MSM in general, and Puerto-Rican MSM in particular (via migration patterns) are sub-optimally reached by evidence-based HIV-prevention and treatment interventions are Miami-Dade County, Orange County, and San Juan Municipio, suggesting the utility of a shared effort to achieve EHE goals across jurisdictions. This proposal seeks to form a strategic alliance across these jurisdictions to enhance implementation efforts, lay the foundation for a multi-site R01 implementation- effectiveness hybrid trial, and reduce HIV disparities among Latino MSM.